THE PSYCHOPHYSIOLOGY OF MULTIPLE PERSONALITY DISORDERS

This project seeks to characterize and quantify cognitive and physiological differences that occur between alter personality states of patients with multiple personality disorder. Alter personalities are studied using a variety of methodologies and technologies. Current efforts are directed at developing a computerized coding system using image processing software for analysis of facial emotional displays.